Ambulatory Methods for Measuring Cognitive Change

Project Summary
Smartphones bring tremendous new opportunities to collect data. These technologies offer capabilities that
allow researchers to overcome many limitations and weaknesses in prior modes of data collection. However,
smartphone data collection has distinct challenges that other data collection modes do not, particularly for
deploying cognitive assessments, which requires stricter standardization than administration of survey
questions. Challenges include participants using their own devices, data security, development costs,
participant engagement, and representative study populations. Researchers have used surveys, interviews,
and diagnostic assessments for decades, but with mobile device research, most of the approaches have not
yet been codified and shared. Many high quality solutions exist, but researchers have independently developed
these procedures, sometimes with duplication of effort and without interoperability beyond a single team.
For conducting research with mobile devices, the field of cognitive aging research urgently needs a model
platform that integrates the tremendous innovations in the field over the past decade and provides a unified
solution to the research community. The Technical Core delivers this solution through the following aims. Aim
1: Augment an existing Android app and build an iOS app that permits researchers to a conduct a variety of
cognitive tests (both graphical and text-based), securely store responses from participants, and securely
transmit responses to a data infrastructure for processing, analysis, and distribution. Aim 2: Build upon an
existing infrastructure to develop a system that administers smartphone data collection, aggregates and
prepares datasets, and allows researchers to query datasets in real time or download data for analysis.
Smartphone data collection administration includes receiving responses from devices as well as pushing out
new measures to participants' devices in response to previous responses. Aim 3: Execute an operation plan
for running and maintaining this integrated smartphone and data infrastructure system. This plan includes
procedures for handling routine maintenance, backups, and unexpected events (network or hardware failures).
The operation plan will support not only the research project outlined in this proposal, but it is also designed to
be a platform for projects from other researchers in the cognitive aging field.
The significance of this Technical Core is that it synthesizes many of the innovative solutions cognitive aging
researchers have developed to use mobile devices in research, and it makes these solutions available to the
entire research community. The innovation is that these solutions are open, flexible, and user-centered: these
features maximize engagement from both researchers and study participants. The impact upon the field is
through the deliverable product: a suite of mobile apps and robust server software for conducting cognitive
aging research.

Public health relevance
Project Narrative Identification of modifiable risk factors prior to the development of neurological conditions in old age represents a critical challenge for developing effective treatment and preventive measures, controlling health care costs, and ultimately improving the quality of life for seniors and their families. This requires methods to detect subtle cognitive changes years prior to the onset of discernable symptoms. The proposed research will significantly advance these efforts by developing innovative ambulatory methods that rely on mobile and sensor technology to measure the cognitive and behavioral function of people in their everyday life. These methods could provide more cost-effective, accurate, sensitive and `ecologically valid' measurements of early signs of cognitive impairment than are currently available through standard laboratory and clinical practices. By improving our ability to measure cognitive function in daily life, this work will set the stage for the next generation of early intervention and prevention studies to slow or prevent cognitive decline.